The PorchLight Project

Project Summary/Abstract
The proposed R01 project will feature a robust collaboration between Lutheran Social Service of Minnesota
(LSS-MN) and the University of Minnesota to evaluate the “Porchlight Project,” a novel adaption of its volunteer
programs that serve older persons with Alzheimer’s disease or Alzheimer’s disease related dementia
(AD/ADRD). The Porchlight Project is multicomponent training delivered to volunteers and includes three
established online training modules on person-centered dementia care; a four-session online training program
that demonstrates to volunteers how to apply person-centered dementia care knowledge to their interactions
with persons with dementia and their caregivers; and ongoing monthly coaching sessions. We will evaluate the
real-world efficacy of the Porchlight Project throughout Minnesota and randomly assign a minimum of 171
persons with AD/ADRD, family caregivers, and volunteers across 19 Regional Program Coordinator regions to
one of two groups: one that receives the Porchlight Project over a 12-month period and a usual care control
condition that receives standard volunteer support. An embedded experimental mixed methods design will be
utilized that will incorporate various qualitative data collection elements within the 12-month randomized
controlled evaluation of the Porchlight Project (Stage III of the NIH Stage Model). Twelve month outcomes that
we hypothesize the Porchlight Project will influence include: 1) increased volunteer competence; 2) increases
in quality of life and reduced loneliness for the person with AD/ADRD; and 3) increased self-efficacy,
decreased stress, and improved well-being for caregivers. The Porchlight Project offers a potentially efficient,
wide-ranging service model for states and communities to implement that can facilitate the “dementia
capability” of their various volunteer programs. Moreover, creating effective linkages to community-based
long-term services and supports addresses several goals of the National Plan to Address Alzheimer’s Disease
as well as the recent Dementia Care Services and Support summits.

Public health relevance
Project Narrative Recommendations of the National Alzheimer’s Project Act as well as the National Research Summits on Care, Services, and Supports for Persons with Dementia and their Caregivers have called for continued creation of innovative, scalable, and sustainable community-based supports for older persons with Alzheimer’s disease and Alzheimer’s disease related dementias (AD/ADRD) and their caregivers. The proposed real-world efficacy trial (Stage III of the NIH Stage Model) features an established collaboration between Lutheran Social Service of Minnesota and the University of Minnesota to evaluate a novel adaption of a statewide volunteer program (the “Porchlight Project”) to assist people with AD/ADRD and their family caregivers better manage dementia at home. If successful, the Porchlight Project will offer a potentially efficient, wide-ranging service model for states and communities to implement for volunteers, persons with AD/ADRD, and family caregivers.